A Transdisciplinary Approach to the Evaluation of Social Determinants of Health s

Project Summary Individual and community health is adversely impacted by disparities in health outcomes for disadvantaged and vulnerable populations. Understanding the underlying causes of health disparities is an essential step in developing interventions designed to ameliorate them and subsequently improve overall community health. This study will examine multiple social determinates that can cause disparities including: deprived neighborhood conditions, inefficient social networks, low socioeconomic status, the presence of hazardous materials in or near a neighborhood, and the lack of access to primary care services with the goal of developing novel and innovated approached to improving community health. First, our collaborative team will look for associations between these social determinants and rates of hospitalizations, emergency department (ED) use, and ED use for primary care treatable or preventable conditions. Second, geospatial models will be developed using both hospital and community level data that will identify local areas where interventions to improve disparities would have the greatest impact. Third, the associations between social determinants and health outcomes as well as the geospatial models will be validated using community surveys and qualitative methods. Fourth, our community's rapidly growing and underserved Hispanic immigrant population will be the target of an intervention informed by the research process and designed, deployed, and evaluated using the geospatial tools and qualitative research findings. The purpose of this intervention will be to reduce health disparities by improving access to and utilization of primary care and preventative services. This project will occur within a primary care practice-based research network using key principles of community-based participatory research. An advisory board of community members, key stakeholders, primary care providers, and research team members will guide the process to assure that all findings are relevant and applicable to the targeted community. All findings will be disseminated through partnering organizations within the research network and will be made available for all community members to assist in the procurement of additional resources and to broaden the scope of the intervention to include all community members that suffer from health disparities.

Public health relevance
Project Narrative This project is designed to ameliorate health disparities by examining the underlying social determinants that can negatively impact the health of underserved and disadvantaged community members - particularly the Hispanic immigrant population. This will be accomplished by using community-based participatory research methods to leverage hospital and community level data to identify at-risk community members who would benefit from enhanced social networks with the aim of helping them to obtain resources and access primary care services. The results of this study will demonstrate the importance of several novel approaches to ameliorating health disparities including the use of community-based participatory research, the effectiveness of interventions that target social networks, and the importance of primary care access in ameliorating health disparities. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS Individual and community health is adversely impacted by a myriad of social determinates, including deprived neighborhood conditions, weak social networks, low socioeconomic status, the presence of hazardous materials in one's living space, and the lack of access to appropriate health services. This proposal will examine the social and cultural contexts that impact community health with the aim of ameliorating health disparities for immigrant populations using a transdisciplinary approach within an established community- based participatory research (CBPR) framework. The research network that will lead this proposal (the Mecklenburg Area Partnership for Primary Care Research, MAPPR) brings together key partners including: Carolinas Healthcare System (CHS), The Mecklenburg County Parks and Recreation Department, The Latin American Coalition, The Charlotte Mecklenburg School System, The Department of Family Medicine, Mecklenburg County Health Department, and the School of Nursing and the Metropolitan Studies research unit at the University of North Carolina at Charlotte. CHS is the third largest public hospital system in the country, and provides healthcare to the majority of our community's immigrant populations. This vertically integrated hospital system uses a standardized billing and clinical data collection system across the 32 facilities, 219 primary care and specialty clinics, and 5 Emergency Departments. This data can be used to determine the impact of various social determinants on health outcomes and closely examine patterns of healthcare utilization. UNC Charlotte's Metropolitan Studies research unit hosts a comprehensive community data repository for Charlotte and Mecklenburg County. Their databases and the associated geographic information system (GIS) are longitudinal and capture community variables at a neighborhood scale for all residences in Mecklenburg County. These data include housing quality and density, socioeconomic status, crime risk, demographics (race, ethnicity, age, gender), access to food, public recreation opportunities, community walkability, and transportation options. The additional community partners, healthcare providers, and academic research team members from each of the partnering organizations have the research experience, history of strong community partnerships, and overall capacity needed to support this project. This team brings together skills in community-based participatory research methods, quantitative analysis, geographic information systems, qualitative data collation and analysis, and intervention design. Together this partnership will be able to develop an understanding of the fundamental social determinants of health outcomes and can map this data to inform the development of effective interventions and to impact policy change. The overall goal of this project is to leverage a transdisciplinary team with expertise and access to community and health services data to improve health outcomes for the community with a particular emphasis on the health of the Hispanic immigrant populations. This goal will be accomplished by leveraging an existing community-based participatory research framework within a regional practice based research network to complete the following aims: Aim 1. To create a centralized database that brings together information from the CHS healthcare system with community-level data including: neighborhood quality of life; socioeconomic status; social networks; and access to healthy foods, preventative health services, and transportation. Aim 2. To identify and map community and neighborhood level social determinants of health Aim 2a: To identify relationships between specific social determinants and health outcomes including hospitalizations, emergency department utilization. Aim 2b: To create geospatial models that identify neighborhoods that would most benefit from increased access to primary care and preventative services. Aim 3. To validate the identified social determinants of health and the geospatial models using qualitative methods and surveys. Aim 4. To design, implement, and evaluate an intervention using community-based participatory research techniques to positively change the social networks of low income immigrant populations with the intent of improving primary care access.